Ultra-high sensitivity, high spatial resolution single photon emission tomography using mechanical flux manipulation

The overall goal of this Phase 2 SBIR proposal is to build on our successfully-implemented
Phase 1 STTR work in which we developed, simulated, built, and validated a new philosophy for
single photon radionuclide (SPR) imaging. We refer to our new imaging methodology as
mechanical flux manipulation (MFM). MFM utilizes high resolution pixelated detectors and a
novel image reconstruction methodology utilizing detector flux information to achieve target
performance goals of >50% detection efficiency for photons impinging an MFM detector and <2
mm reconstructed image resolution. The two main features that differentiate MFM from
traditional SPECT are collimator-less detectors and the use of probability distributions versus
line of response (LOR) counts to reconstruct images. MFM does not bin individually detected
photons to a LOR. The direction of travel for individual photons is not considered. MFM is
further differentiated from SPECT in that it uses a fully 3D image reconstruction and reaps the
imaging benefits similar to 3D versus 2D PET data acquisition and image reconstruction. While
MFM will support general single photon tomographic imaging protocols, our initial focus is to
demonstrate feasibility for human brain imaging.
This project is consists of three specific aims. Aims 1 and 2 are an iterative process of building
(SA1) and testing (SA2) an MFM tomographic imaging system with 2 detector panels. We will
first build a single detector panel for the MFM system (SA1-A) that will be used to acquire
phantom data to assess the capabilities of the single-panel MFM system (SA2-A). The single-
panel MFM system will be evaluated for usability, machine tolerances, and precision of control.
After this evaluation, we will make any necessary changes and build a second MFM detector
panel to integrate into the system (SA1-B). The 2-panel MFM system will then be evaluated via
phantom studies including the striatal brain phantom and the miniDerenzo Phantom. These will
be used to evaluate resolution, contrast, uniformity, noise, and overall image quality (SA2-B).
Acquisition and reconstruction settings will be chosen based on phantom imaging performance.
Our third aim is to perform human brain imaging using the 2-panel MFM system. We will obtain
a minimal-risk IRB and recruit 4 patients that have been referred for I-123 Ioflupane SPECT
imaging for differential Parkinson’s diagnosis. We will ask patients to walk a short distance from
their SPECT imaging session and be scanned an additional 15-20 minutes in our MFM system
while the radiotracer is still in their brain. Human brain images will be evaluated by an
experienced radiologist.

Public health relevance
The overall goal of this project is to demonstrate feasibility of a new single photon radionuclide imaging technology with >1000 times the sensitivity and >100 times the volumetric image resolution of current clinical SPECT systems. We refer to this new imaging technology as ‘mechanical flux manipulation’ or MFM.